LUNG MACROPHAGE ANTIGEN: A MARKER OF AGE AND FUNCTION?

The importance of pulmonary macrophages in the lung is increasingly evident. Not only do they ingest and kill pathogens but their secretory products regulate the activities of lymphocytes, fibroblasts, neutrophils, and other cells. Changes in the renewal of lung macrophages are related to environmental stimuli. We have identified an antigen specific for pulmonary macrophages in hamsters and have shown that this antigen develops only after these cells appear on the alveolar surface. We have produce monoclonal antibodies to this antigen and have developed methods to quantify antigen on individual cells using fluorescence activated flow cytometry and sorting. The purpose of this research is to describe pulmonary macrophage heterogeniety, function and differentiation using this antigen and our monoclonals as investigative tools. We will correlate the amount of antigen on lung macrophages with parameters of macrophage differentiation and function in normal adults animals. In addition, we will make these correlations in fetal and neonatal lungs as well as in adult animal lungs altered by infection and interestitial inflammatory lung disease. Since we have found that our monoclonal antibody can specifically inhibit ingestion of albumin coated latex beads, we will continue in vitro studies of factors which regulate differentiation with emphasis on the role of this antigen in phagocytosis. Finally, we intend to use our monoclonal antibody in vivo to deplete and/or block pulmonary macrophage actions to define other defensive mechanisms available to the lung when macrophages are rendered non-functional.